Mapping Mitochondrial Diversity in the Aging Brain and Immune System

The brain and immune system are fueled by energy flow through mitochondria – dynamic, multifunctional
organelles that convert energy and act as intracellular signaling hubs within neural, glial, and immune cells.
Converging lines of research indicate that mitochondrial alterations likely arise with aging and play a causal role
in the pathogenesis of Alzheimer’s disease (AD). However, progress in testing this hypothesis with a sufficient
level of rigor and specificity has been hindered by the lack of approaches to address the diversity of mitochondrial
phenotypes among different tissues and cell types. To profile multiple AD-relevant aspects of mitochondrial
biology at a sufficient level of biological specificity, we have developed a simple computational approach that
groups all known mitochondrial genes into functional pathways, measures their relative expression using omics
data (RNA sequencing), and yields a fine-grained, interpretable picture of mitochondrial phenotypes – termed
mitotypes. In this proposal, we deploy our mitotyping approach at single-cell resolution in two organ systems
implicated in AD pathogenesis: the brain and immune system. In Aim 1, we propose to generate sensitive
mitotype profiles for >1.4M brain cortical cells (neurons, glia, other cell types) across 381 older adults. This will
establish cell type-specific mitochondrial recalibrations associated with age, among women and men, and allow
the discovery of specific mitotype signatures associated with cognitive reserve and AD. In Aim 2, we deploy the
same approach in >0.9M circulating immune cells from 175 adults ages 20-80, establishing sex-specific immune
mitotypes associated with age, cognitive reserve, and AD. Computationally, brain and immune mitotypes are
entirely compatible, therefore allowing us to harmonize datasets from both cohorts to identify potential shared
abnormal mitochondrial features across the brain and immune cells in persons with cognitive impairment,
dementia, and/or AD. Mechanistically, among the various domains of mitochondrial biology, previous research
has specifically, but not exclusively, implicated defects in the mitochondrial oxidative phosphorylation (OxPhos)
in AD pathogenesis. Therefore, in Aim 3 we use i) our Cellular Lifespan system to dissect the effects of targeted
genetic and pharmacological OxPhos perturbations on mitotype signatures in living human cells over time, ii) a
co-culture system to examine how a mitochondrial OxPhos impairment in one cell population influences the
mitotype of another cell population, revealing new principles of mitotype crosstalk or “contagion” between cells;
and iii) a unique cohort of patients with genetically-defined, bioenergetically-profiled mitochondrial OxPhos
defects to examine, in the human brain-body system, how OxPhos defects influence other domains of
mitochondrial biology as reflected in circulating immune cell mitotypes. Finally, in Aim 4 we develop an online
platform, MitotypeExplorer 2.0, which makes mitotyping accessible to the growing community of neuroscientists,
immunologists, and other interdisciplinary investigators interested in uncovering the role of age-related
mitochondrial impairments and recalibrations in human health and disease.

Public health relevance
NARRATIVE Impaired mitochondrial biology in brain and immune cells is an emerging candidate mechanism for Alzheimer’s disease (AD) pathogenesis, but rigorously testing this hypothesis requires scalable approaches to profile mitochondrial phenotypes will cell-type specific resolution. In this proposal, we develop for public use and deploy a novel mitochondrial phenotyping approach – mitotyping – in brain cortical cells (ROSMAP cohort, n=381) and in circulating immune cells (RANN/CR cohort, n=175), and link the resulting cell type-specific mitotype alterations to age, cognitive reserve, and AD pathology among women and men. Mechanistically, we also deepen our understanding of mitotypes by complementing these studies with in vitro experiments that establish how primary energetic mitochondrial perturbations dynamically alter other domains of mitochondrial biology within single cells, between cells, and among immune cells of patients with rare mitochondrial DNA defects, thereby providing a novel approach, framework, and foundation to explore the role of mitochondrial alterations in human health and disease.